Diversity Supplement: Manipulation of Host Tissue to Induce a Hierarchical Microvasculature

Summary (Parent Grant)
Reconstructive surgeons are tasked with the restoration of soft tissue loss irrespective of etiology. Over the past
two decades, hydrogel scaffolds have become a vital platform for tissue revascularization and surgical repair.
However, their slow and random vascularization upon implantation often precipitates failure and precludes true
tissue regeneration and function. Native microvascular networks are characterized by organized tree-like
branching patterns that originate from large feeding vessels. Our objective is to utilize complementary
regenerative strategies based upon rigorous preliminary data that enables the rapid development of this
hierarchical microvasculature. To achieve our objective, we recently developed an innovative microsurgical
tactic termed vascular micropuncture (MP). In this method, small perforations are created using a needle in the
recipient vasculature to facilitate cellular extravasation and angiogenesis, without causing thrombosis or
significant hemorrhage. Such induced angiogenesis can be used to randomly vascularize an adjacently placed
hydrogel scaffold, leading to perfusion within 24 h and a doubling of neovascularization. With this compelling
result, we propose to advance the MP method using an emerging in situ microengineering technology. We have
developed granular hydrogel scaffolds (GHS) based on an extracellular matrix mimetic material with controlled
microporosity that improves cell infiltration and guides vascular network formation both in vitro and in vivo.
Our hypothesis is that customized GHS can be synergistically used with MP to hasten and precisely guide
hierarchical microvascular development. To test this hypothesis, we will focus on the following three independent
specific aims: 1) To design and optimize GHS to guide microvascular development, 2) To evaluate the effect of
MP characteristics to hasten microvascular development and 3) To evaluate the coupling effects of MP and GHS
to hasten and precisely guide hierarchical microvascular development. The successful completion of these
studies should markedly improve the vascularization of scaffolds used in soft tissue reconstructive surgery. Also,
it sets the platform for further investigation in building a hierarchical microvasculature that is cornerstone to blood
flow regulation, oxygen diffusion, and immune cell modulation. Consequently, our novel approach holds
immense potential for broadly advancing regenerative medicine.

Public health relevance
Project Narrative (Parent Grant) The proposed research is relevant to public health and aims at understanding how coordinated approaches can be used to rapidly guide microvascular development. This will enable new and translatable reconstructive approaches for tissue loss, and broadly advance regenerative medicine.